AKT-Vimentin interaction; a potential role in soft tissue sarcoma progression and

DESCRIPTION (provided by applicant): Soft tissue sarcomas (STS) constitute a family of mesenchymal -origin malignancies that can occur anywhere in the body. Comprising more than 50 distinct histological subtypes, STS share several distinctive features that include frequent local recurrence after definitive therapy, marked chemoresistance, and frequent metastasis, especially to the lungs. These features translate to a dismal outcome, especially for those patients harboring high grade complex karyotype STS histologies, consisting mainly of leiomyosarcoma and high grade pleomorphic sarcoma (malignant fibrous histiocytoma and fibrosarcoma). To improve STS therapeutic outcome it will be critical to develop novel agents that capitalize on underlying STS points of molecular vulnerability;however, progress towards this urgent goal are hampered by our minimal understanding of the molecular determinants underlying STS progression and dissemination. Tumor cells, including STS, respond to signaling cascades that control growth regulation processes and other components of the malignant process such as motility, invasion, induction of apoptosis, etc. Among these signaling mechanisms, the AKT kinase pathway may be particularly important in STS growth and dissemination. Phosphorylation of AKT is a critical step in this cascade, had has been associated with impaired STS prognosis when identified in STS tissues. In human STS cell lines and human STS xenografts growing in immuno -incompetent mice, AKT inhibition interferes with STS growth, perhaps by disrupting AKT interaction with vimentin, a critical structural protein that may also have oncologically-relevant functional properties. Our group is apparently the first to identify the existence of AKT -vimentin interactions. We propose to study the regulation of this interaction, hoping to learn more about the mechanisms underlying these interactions, the functional significance of this interaction regarding how it impacts on STS proliferation and metastasis in vivo, and finally to test preclinical therapeutic approaches to AKT and vimentin blockade, hoping to demonstrate preclinical relevance using human STS xenograft mouse models and murine sarcoma models. PUBLIC HEALTH RELEVANCE: Soft tissue sarcoma is a form of malignancy that occurs anywhere in the body and is ultimately lethal to approximately 50% of those afflicted, usually secondary to uncontrollable local or distant tumor recurrence especially in the subset of complex Karyotype high grade pleomorphic sarcomas. The process of dissemination is not adequately controlled due to our lack of knowledge of pertinent molecular pathways driving the proliferation and dissemination of this disease. This research focuses on one such pathway which appears to be particularly active in soft tissue sarcoma (the AKT regulation of vimentin expression and function) which may ultimately prove to be relevant as a potential point of soft tissue sarcoma therapeutic vulnerability.

Public health relevance
Project Narrative Soft tissue sarcoma is a form of malignancy that occurs anywhere in the body and is ultimately lethal to approximately 50% of those afflicted, usually secondary to uncontrollable local or distant tumor recurrence especially in the subset of complex Karyotype high grade pleomorphic sarcomas. The process of dissemination is not adequately controlled due to our lack of knowledge of pertinent molecular pathways driving the proliferation and dissemination of this disease. This research focuses on one such pathway which appears to be particularly active in soft tissue sarcoma (the AKT regulation of vimentin expression and function) which may ultimately prove to be relevant as a potential point of soft tissue sarcoma therapeutic vulnerability.